High Pressure Liquid Chromatography (HPLC) System for Analyzing Bacterial Lipoprotein Biosynthesis and Oxidation

PROJECT SUMMARY / ABSTRACT
The long-term goal of the application is to understand why and how bacterial lipoproteins in the medically
important Firmicutes phylum are structurally modified. Lipoproteins are ubiquitous membrane associated
proteins tethered to the bacterial surface through a conserved acylated cysteine residue located at the
N-terminus. However, lipoprotein acylation states can vary in chain number, length, and attachment
position depending on the bacterial source. Acylation states are also dynamically regulated in the same
strain by particular growth environments, including by excess copper which induces expression of select
N-terminal modifying genes. This project aims to utilize ultra high-pressure liquid chromatography (uHPLC) to
characterize reconstituted lipoprotein N-terminal modification systems in vitro. Assays will help
determine enzyme mechanisms, identify acyl chain donors, and to test important active site residues. The
second part of the project will utilize HPLC to isolate and purify various model lipopeptides representing
each of the known N-terminal chemotype classes (free a-amino, N-acyl, N-acetyl, and lyso-form). The
chemotype panel will then be analyzed for copper binding and susceptibility to oxidation. The project will thus
advance our understanding of acyl transfer biochemistry and provide insight on the physiological function of
lipoprotein modifications.

Public health relevance
PROJECT NARRATIVE Bacterial lipoproteins are structures located on the surface of all bacteria that are critical to bacterial fitness and their potential to cause infections since they are key recognition determinants of the immune system. This project aims to characterize the biosynthetic enzymes that make different lipoprotein structural forms by using ultra high-pressure liquid chromatography (uHPLC) assays.